VWF-GPIba binding and von Willebrand Disease

? DESCRIPTION (provided by applicant): The broad, long-term objective of the proposed research is to determine the mechanisms of von Willebrand Factor (VWF) function. We will study the binding of the VWF A1 domain to platelet glycoprotein Ibα (GPIbα). We hypothesize, based on crystal structures and single molecule measurements of A1-GPIbα unbinding, that force can regulate the binding of A1 to GPIbα by switching the A1-GPIBα bond into a high affinity state. The high affinity state potentially mimics the state of the A1 domain induced by ristocetin, an antibiotic that promotes VWF mediated platelet agglutination. We propose to measure the on- and off-rates of A1-GPIbα binding to gain a mechanistic understanding of its regulation by force and ristocetin. Specific Aim 1: Characterize the affect of Ristocetin on A1-GPIbα bond kinetics. We will generate A1 domain constructs with and without ristocetin binding epitopes. A1-GPIbα binding kinetics and affinity will be measured in the presence and absence of ristocetin using Surface Plasmon Resonance (SPR). These measurements will quantitatively determine how ristocetin enhances A1-GPIbα binding, which is important for the diagnosis and treatment of Von Willebrand Disease (VWD). This aim will provide novel training for the fellow in recombinant protein expression in mammalian cells, protein purification and immobilization, and SPR. Specific Aim 2: Determine the force-dependent on-rate of A1-GPIbα. We have designed a Receptor and Ligand in a Single Molecule (ReaLiSM) containing the VWF A1 domain linked by a polypeptide chain to GPIbα. ReaLiSM allows repeated measurements of unbinding and binding using laser tweezers. We will measure the Wild Type, A1-GPIbα on-rate as a function of force +/- ristocetin using ReaLiSM. The results will determine whether flexing between a high and low affinity state can enhance A1-GPIbα binding. The fellow will receive training in all experimental and computational aspects of single molecule force spectroscopy. Specific Aim 3: Characterize the bond kinetics of gain-of-function (GOF) A1 and GPIbα mutations to understand the basis of Von Willebrand Disease (VWD). Using laser tweezers and SPR, we will measure the binding kinetics and mechanical properties of A1- GPIbα containing VWD-2B and platelet-VWD (PT-VWD) mutations. The results will quantify the mechanical effects of these VWD mutations on binding kinetics, and will determine whether a combination of mutations can shift the bond into a single, high affinity state.

Public health relevance
PUBLIC HEALTH RELEVANCE: Von Willebrand factor binds to platelets during blood clotting to prevent hemorrhaging of blood at the site of vessel injury. We will investigate how pathological mutations that cause von Willebrand disease alter the ability of von Willebrand factor to bind platelets; and, on a more basic level, we will determine how von Willebrand factor is able to bind platelets despite being opposed by the high forces of the rapidly moving blood stream. Our research is important for the diagnosis and treatment of von Willebrand factor related bleeding disorders.